Evaluating Breast Pumping Protocol Efficiency and Elucidating Molecular and Cellular Mechanisms of Enhanced Milk Production

Human milk provides optimal nutrition for infants; however, only 25% of U.S. mothers achieve the
breastfeeding targets recommended by the Centers for Disease Control, which emphasize six months of
exclusive breastfeeding. Suboptimal breastfeeding practices have profound public health consequences,
costing the U.S. an estimated $13 billion annually and resulting in the preventable deaths of over 900
infants. These outcomes are often attributed to early breastfeeding cessation or the inability to sustain
exclusive breastfeeding, with low milk production being the most frequently cited reason. Additional
challenges include concerns about milk composition and quality. Insufficient milk production negatively
impacts infant growth, maternal mental health, and maternal experiences overall, yet the physiological
mechanisms underlying these issues remain poorly understood, and treatment options are very limited.
The proposed research seeks to address these critical issues by employing a randomized clinical trial
design alongside molecular insights into mammary gland biology. This study will include three intervention
arms: (1) instructions to pump after breastfeeding session 6-8 times per day, (2) instructions to pump
following breastfeeding sessions only 3-4 times per day, and (3) no specific instructions to add pumping
sessions. The trial will span 14 days, during which maternal milk production, mammary gland
transcriptomic changes, and milk composition alterations will be tracked and analyzed. Participants will
provide milk and blood samples, detailed records of expressed milk volume, and daily questionnaires
tracking breastfeeding and pumping schedules. This research combines a robust randomized trial design
with innovative molecular analyses, such as RNA-seq of milk-derived transcripts profiling, to elucidate
changes in mammary gland function and secretory processes resulting from these clinical interventions.
This interdisciplinary strategy directly aligns with the mission of the Eunice Kennedy Shriver National
Institute of Child Health and Human Development (NICHD) to advance knowledge of maternal and infant
health. By integrating clinical and molecular approaches, this project seeks to generate evidence-based
strategies to improve breastfeeding outcomes, providing crucial insights into both the physiological and
clinical factors underlying low milk production and lactation challenges.

Public health relevance
This research aims to address the public health burden caused by suboptimal breastfeeding practices, which result in high infant morbidity and mortality rates and impose significant economic costs. By targeting physiological barriers to milk production, this project could provide evidence-based solutions to improve breastfeeding outcomes for mothers and infants, ultimately improving health and well-being at a population level.